Novel heterologous listeria-adenovirus mucosal vaccine for HIV-1

. Project Summary/Abstract AIDS continues to be an expanding pandemic. The successful development of a safe and effective HIV vaccine is a global health priority that has been hampered by our current inability to deliver HIV antigens efficiently to the immune system to prime predictable, high frequency, and durable immune responses in humans. To approach this problem, we propose a unique prime-boost vaccine strategy that pairs two live mucosal vectors, Listeria monocytogenes (Listeria, Lm) and adenovirus (Ad), each of which has been tested in clinical trials in humans, and both have shown the ability in small animal models and NHP to elicit strong cellular immunity. The proposal is provoked by our recent observations that mucosal administration of attenuated Listeria followed by a boost by replication-incompetent Ad5 elicited potent peripheral and mucosal T cell responses, and by the development of new Ad variants that circumvent anti-Ad5 immunity. Because most HIV infections result from heterosexual transmission to women, and because the virus targets lymphocytes in the gut and vaginal mucosae for rapid elimination, this project aims by use of these vectors to strengthen immunity and protection at these important mucosal sites. The laboratories of Drs. Dan Barouch at Beth Isreal Deaconess Medical Center and Fred Frankel at the University of Pennsylvania School of Medicine will collaborate to explore the potential synergy of these two vectors. Dr. Frankel will examine vector interactions in mice, while Dr. Barouch will conduct concurrent pilot studies testing these vectors in the nonhuman primate model.

Public health relevance
Updated Other Support for all key personnel IACUC verification statement/letter with approval date (at Penn) IACUC verification statement/letter with approval date (at BIDMC: see specifically protocol page 7, experiments 3 and 4) The minor change of scope needed to accomplish the proposed work within 1 year of funding was negotiated in close communication with my NIAID program officer, Dr. Vijay Mehra. I hope you find all of the material to be in order. Thank you for your help in this matter. Sincerely, Fred R. Frankel, Professor of Microbiology 203C Johnson Pavilion � 3610 Hamilton Walk � Philadelphia, PA 19104-6076 � 215-898-8730 � Fax 215-898-9557 Principal Investigator/Program Director (Last, first, middle): Frankel, Fred FROM THROUGH DETAILED BUDGET FOR INITIAL BUDGET PERIOD DIRECT COSTS ONLY PERSONNEL (Applicant organization only) NAME ROLE ON PROJECT Months Devoted to Project 09/01/09 SALARY REQUESTED 08/31/10 FRINGE BENEFITS DOLLAR AMOUNT REQUESTED (omit cents) INST.BASE SALARY TOTAL Cal. Mnths Acad. Mnths Sum. Mnths Fred Frankel Sufen Li TBN Principal Investigator 4.8 12 12 138,699 31,620 37,368 55,480 31,620 37,368 16,422 9,360 3,625 71,902 40,980 40,993 Res. Spec Post Doc SUBTOTALS CONSULTANT COSTS 124,468 29,407 153,875 0 EQUIPMENT (Itemize) Freezer SUPPLIES (Itemize by category) 8,000 Bacterial culture medium and supplies 11,000 Animal purchase and care 16,000 FACS analysis and immunological reagents 15,000 Tissue culture costs 4,000 General lab supplies 3,255 TRAVEL PATIENT CARE COSTS 49,255 2,000 INPATIENT OUTPATIENT ALTERATIONS AND RENOVATIONS (Itemize by category) OTHER EXPENSES (Itemize by category) Post Doc health insurance Shared services CONSORTIUM/CONTRACTUAL COSTS 3,500 4,080 ALLOWABLE PER F AND A AGREEMENT DIRECT COSTS 7,580 257,430 SUBTOTAL DIRECT COSTS FOR INITIAL BUDGET PERIOD (Item 7a, Face Page) CONSORTIUM/CONTRACTUAL COSTS FACILITIES AND ADMINISTRATION COSTS $220,710 180,201 TOTAL DIRECT COSTS FOR INITIAL BUDGET PERIOD PHS 398 (Rev. 11/07) Page $658,341 Form Page 4 note: original requested TDC 679,513 Updated Personnel Justification (at University of Pennsylvania) Dr. Fred Frankel is a Professor of Microbiology at the University of Pennyslvania and will serve as Principal Investigator for this combined research effort. He will increase his effort devoted to this project to 40% (4.8 calendar months). He will oversee and assume scientific responsibility for all of its aspects. He will directly supervise the research of Sufen Li, and one new post-doctoral researcher. A new post-doctoral researcher, to be named, will devote 100% effort (12 calendar months) to the project during this year. This individual will be responsible for examination of the immune interactions of Listeria and adenovirus vaccines. With the expertise and input of Dr. Michael Betts of this Department, he will assume responsibility for developing the use of polychromatic flow cytometry in our laboratory, which will be needed to analyze the complete immune response in mouse tissues to each of the vaccine vectors, and their combinations. All work will be under the direct supervision of Dr. Frankel. Sufen Li, research specialist, will devote 100% effort (12 calendar months) to this project. She has had microbiology and molecular biology training, and holds a M.Sc. degree from the University of Tsukuba, Japan, and will assist the post-doctoral researcher and myself in biological and immune assays, animal experiments, and general lab maintenance. She will also assist in the preparation of the pol, env, and nef recombinants. Her many responsibilities will include (1) the preparation and full characterization of the doses of bacteria that will be used for monkey vaccinations; (2) use of molecular biological techniques to characterize these and other strains of bacteria needed for the project; (3) continue in her role as lab manager, maintaining stocks of laboratory supplies and monitoring our purchases; (4) aid in tissue isolations and provide backup for immune assays of vaccinated mice. She will work under the supervision of Dr. Frankel and the new post-doctoral researcher. Principal Investigator/Program Director (Last, first, middle): Frankel, Fred/Subcontract PI: Barouch, Dan H. FROM THROUGH DETAILED BUDGET FOR INITIAL BUDGET PERIOD DIRECT COSTS ONLY PERSONNEL (Applicant organization only) NAME ROLE ON PROJECT Months Devoted to Project 09/01/09 SALARY REQUESTED 08/31/10 FRINGE BENEFITS DOLLAR AMOUNT REQUESTED (omit cents) INST.BASE SALARY TOTAL Cal. Mnths Acad. Mnths Sum. Mnths Dan Barouch Diana Lynch Jinyan Liu Principal Investigator 0.6 12 3 186,600 43,310 51,992 9,330 43,310 12,998 2,519 9,961 2,990 11,849 53,271 15,988 Res. Asst Post Doc SUBTOTALS CONSULTANT COSTS 65,638 15,470 81,108 0 EQUIPMENT (Itemize) 0 SUPPLIES (Itemize by category) Rhesus monkey costs Immunologic assay costs Other lab supplies 113,112 12,810 50,400 176,322 TRAVEL 0 PATIENT CARE COSTS INPATIENT OUTPATIENT ALTERATIONS AND RENOVATIONS (Itemize by category) OTHER EXPENSES (Itemize by category) 0 CONSORTIUM/CONTRACTUAL COSTS DIRECT COSTS SUBTOTAL DIRECT COSTS FOR INITIAL BUDGET PERIOD (Item 7a, Face Page) CONSORTIUM/CONTRACTUAL COSTS FACILITIES AND ADMINISTRATION COSTS $257,430 $257,430 TOTAL DIRECT COSTS FOR INITIAL BUDGET PERIOD PHS 398 (Rev. 11/07) Page Form Page 4 Program Director/Principal Investigator (Last, First, Middle): Frankel, Fred CHECKLIST TYPE OF APPLICATION (Check all that apply.) NEW application. (This application is being submitted to the PHS for the first time.) RESUBMISSION of application number: 1R01-AI-078779-01A2 (This application replaces a prior unfunded version of a new, renewal, or revision application.) RENEWAL of grant number: (This application is to extend a funded grant beyond its current project period.) REVISION to grant number: (This application is for additional funds to supplement a currently funded grant.) CHANGE of program director/principal investigator. Name of former program director/principal investigator: CHANGE of Grantee Institution. FOREIGN application Name of former institution: List Country(ies) Involved: Domestic Grant with foreign involvement No Yes If "Yes," INVENTIONS AND PATENTS (Renewal appl. only) Previously reported Not previously reported 1. PROGRAM INCOME (See instructions.) All applications must indicate whether program income is anticipated during the period(s) for which grant support is request. If program income is anticipated, use the format below to reflect the amount and source(s). Budget Period Anticipated Amount Source(s) N/A 2. ASSURANCES/CERTIFICATIONS (See instructions.) In signing the application Face Page, the authorized organizational representative agrees to comply with the policies, assurances and/or certifications listed in the application instructions when applicable. Descriptions of individual assurances/certifications are provided in Part III and listed in Part I, 4.1 under Item 14. If unable to certify compliance, where applicable, provide an explanation and place it after this page. 3. FACILITIES AND ADMINSTRATIVE COSTS (F&A)/ INDIRECT COSTS. See specific instructions. DHHS Agreement dated: 05/15/09 No Facilities And Administrative Costs Requested. Regional Office. Date DHHS Agreement being negotiated with No DHHS Agreement, but rate established with CALCULATION* (The entire grant application, including the Checklist, will be reproduced and provided to peer reviewers as confidential information.) a. Initial budget period: b. 02 year c. 03 year d. 04 year e. 05 year Amount of base $ Amount of base $ Amount of base $ Amount of base $ Amount of base $ 237,710 x Rate applied x Rate applied x Rate applied x Rate applied x Rate applied 59%/60 % = F&A costs % = F&A costs % = F&A costs % = F&A costs % = F&A costs $ $ $ $ $ $ 140,645 TOTAL F&A Costs *Check appropriate box(es): Salary and wages base Modified total direct cost base 140,645 380 Other base (Explain) Off-site, other special rate, or more than one rate involved (Explain) Explanation (Attach separate sheet, if necessary.): 7/1/09-6/30/10 59% after 7/1/10 60% 4. DISCLOSURE PERMISSION STATEMENT: If this application does not result in an award, is the Government permitted to disclose the title of your proposed project, and the name, address, telephone number and e-mail address of the official signing for the applicant organization, to organizations that may be interested in contacting you for further information (e.g., possible collaborations, investment)? PHS 398 (Rev. 11/07) Page Yes No Checklist Form Page Program Director/Principal Investigator (Last, First, Middle): Frankel, Fred R.; Subcontract PI: Barouch, Dan. CHECKLIST TYPE OF APPLICATION (Check all that apply.) NEW application. (This application is being submitted to the PHS for the first time.) RESUBMISSION of application number: 1R01-AI-078779-01A2 (This application replaces a prior unfunded version of a new, renewal, or revision application.) RENEWAL of grant number: (This application is to extend a funded grant beyond its current project period.) REVISION to grant number: (This application is for additional funds to supplement a currently funded grant.) CHANGE of program director/principal investigator. Name of former program director/principal investigator: CHANGE of Grantee Institution. FOREIGN application Name of former institution: List Country(ies) Involved: Domestic Grant with foreign involvement No Yes If "Yes," INVENTIONS AND PATENTS (Renewal appl. only) Previously reported Not previously reported 1. PROGRAM INCOME (See instructions.) All applications must indicate whether program income is anticipated during the period(s) for which grant support is request. If program income is anticipated, use the format below to reflect the amount and source(s). Budget Period Anticipated Amount Source(s) N/A 2. ASSURANCES/CERTIFICATIONS (See instructions.) In signing the application Face Page, the authorized organizational representative agrees to comply with the policies, assurances and/or certifications listed in the application instructions when applicable. Descriptions of individual assurances/certifications are provided in Part III and listed in Part I, 4.1 under Item 14. If unable to certify compliance, where applicable, provide an explanation and place it after this page. 3. FACILITIES AND ADMINSTRATIVE COSTS (F&A)/ INDIRECT COSTS. See specific instructions. DHHS Agreement dated: 5/19/09 No Facilities And Administrative Costs Requested. Regional Office. Date DHHS Agreement being negotiated with No DHHS Agreement, but rate established with CALCULATION* (The entire grant application, including the Checklist, will be reproduced and provided to peer reviewers as confidential information.) a. Initial budget period: b. 02 year c. 03 year d. 04 year e. 05 year Amount of base $ Amount of base $ Amount of base $ Amount of base $ Amount of base $ 257,430 x Rate applied x Rate applied x Rate applied x Rate applied x Rate applied 70 % = F&A costs % = F&A costs % = F&A costs % = F&A costs % = F&A costs $ $ $ $ $ $ 180,201 TOTAL F&A Costs *Check appropriate box(es): Salary and wages base Modified total direct cost base 180,201 380 Other base (Explain) Off-site, other special rate, or more than one rate involved (Explain) Explanation (Attach separate sheet, if necessary.): 4. DISCLOSURE PERMISSION STATEMENT: If this application does not result in an award, is the Government permitted to disclose the title of your proposed project, and the name, address, telephone number and e-mail address of the official signing for the applicant organization, to organizations that may be interested in contacting you for further information (e.g., possible collaborations, investment)? PHS 398 (Rev. 11/07) Page Yes No Checklist Form Page Modified Project Summary/Abstract Section AIDS continues to be an expanding pandemic. The successful development of a safe and effective HIV vaccine is a global health priority that has been hampered by our current inability to deliver HIV antigens efficiently to the immune system to prime predictable, high frequency, and durable immune responses in humans. To approach this problem, we propose a unique prime-boost vaccine strategy that pairs two live mucosal vectors, Listeria monocytogenes (Listeria, Lm) and adenovirus (Ad), each of which has been tested in clinical trials in humans, and both have shown the ability in small animal models and NHP to elicit strong cellular immunity. The proposal is provoked by our recent observations that mucosal administration of attenuated Listeria followed by a boost by replication-incompetent Ad5 elicited potent peripheral and mucosal T cell responses, and by the development of new Ad variants that circumvent anti-Ad5 immunity. Because most HIV infections result from heterosexual transmission to women, and because the virus targets lymphocytes in the gut and vaginal mucosae for rapid elimination, this project aims by use of these vectors to strengthen immunity and protection at these important mucosal sites. The laboratories of Drs. Dan Barouch at Beth Isreal Deaconess Medical Center and Fred Frankel at the University of Pennsylvania School of Medicine will collaborate to explore the potential synergy of these two vectors. Dr. Frankel will examine vector interactions in mice, while Dr. Barouch will conduct concurrent pilot studies testing these vectors in the nonhuman primate model. Modified Specific Aims Section LISTERIA-PRIME HETEROLOGOUS-BOOST MUCOSAL VACCINES FOR HIV-1 The AIDS pandemic continues unchecked, and is now the leading cause of death in Africa and fourth leading cause of death worldwide. The successful development of a safe and effective HIV vaccine is a global health priority that has been hampered by our current inability to deliver HIV antigens efficiently to the immune system to prime predictable, high frequency, and durable immune responses in humans. To approach this problem, we propose a unique prime-boost vaccine strategy that pairs two live mucosal vectors, Listeria monocytogenes (Listeria, Lm) and adenovirus (Ad), each of which has been tested in clinical trials in humans, and both have shown the ability in small animal models and nonhuman primates to elicit strong cellular immunity. The proposal is provoked by our recent observations that mucosal administration of attenuated Listeria followed by a boost by replication-incompetent rAd5 elicited potent peripheral and mucosal T cell responses, and by the development of new Ad variants that circumvent anti-Ad5 immunity. Because most HIV infections result from heterosexual transmission to women, and because the virus targets lymphocytes in the gut and vaginal mucosa for rapid elimination, this project aims by use of these vectors to strengthen immunity and protection at these important mucosal sites. The laboratories of Drs. Dan Barouch at Beth Isreal Deaconess Medical Center and Fred Frankel at the University of Pennsylvania School of Medicine will collaborate to explore the potential synergy of these two vectors. Dr. Frankel will examine vector interactions with the new Ad variants in mice, while Dr. Barouch will conduct studies of these vectors in the nonhuman primate model. While rAd-based vaccines have been shown to elicit robust antigen-specific humoral and cellular immune responses in naive subjects in preclinical and clinical studies, the effectiveness and safety of rAd5 vectors has been questioned following the recent STEP trial. Therefore we plan to evaluate rare serotype rAd variants such as rAd26 which are biologically different than rAd5 and exhibit improved T cell polyfunctionality. Listeria, an intracellular bacterial pathogen not restricted by preexisting anti-vector immunity, has shown promising antigen-specific cellular immune responses in preliminary monkey studies. We propose the joining of attenuated variants of these novel rAd and rLm vectors in a prime-boost platform to raise potent T cell responses in the genital/rectal and gastrointestinal compartments. Since each of these natural mucosal vectors confronts the host through different sets of pathogen-associated molecular signals and activates different host response elements (39, 65, 82), we anticipate that a potent, highly diverse polyfunctional T cell response will be elicited. We therefore hypothesize that our novel heterologous rLm/rAd vaccine regimen will induce potent mucosal immune responses in both mice and rhesus monkeys and will afford protection against mucosal SIV challenges. Our two Specific Aims are: Specific Aim 1. Test the hypothesis that a heterologous rLm/rAd prime-boost protocol can elicit stronger and qualitatively more effective peripheral and mucosal immunity in mice than the present "gold standard" of HIV vaccinology: DNA prime--adeno boost, and generate Lm constructs that express additional SIV gene products. Specific Aim 2. Define the optimal heterologous rLm/rAd prime-boost regimen in rhesus monkeys by multiparameter flow phenotyping to assess peripheral and mucosal immunity. Modified Public Health Relevance Section As new HIV infections continue to occur at alarming rates (over 6,000 new infections every day), development of a strong and effective mucosal vaccine would have a huge public health impact. No vaccine has yet proven effective. Thus there is a profound need for new approaches of HIV-1 vaccination. This project focuses on the potential use of attenuated Listeria monocytogenes as a live mucosal vaccine vector to prime strong immune responses for subsequent boost by the heterologous viral vector, Ad26. Such a novel prime-boost protocol may serve to greatly strengthen and diversify the function and phenotype of resulting immune responses and lead to protective immunity. Updated Other Support for All key personnel At University of Pennsylvania On-going research support: 1 R21 AI 071774-01 Frankel, F. R. (P.I.) (12% Effort; 1.44 Cal Months) 08/01/07--07/31/09 NIH/NIAID Vaginal immunity after intranasal Listeria vaccination The goal of this project is to examine the safety and immunogenicity of attenuated strains of Listeria monocytogenes, particularly in mucosal tissues, following intranasal infections. Pending: PR093169 Frankel, F. R. (P.I.) (40% Effort; 4.8 Cal Months) 02/01/10--01/31/13 DOD Listeria Vaccine for DHIV/AIDS This project was designed to develop and test new Listeria vectors for HIV. There will be some overlap with current application. At BIDMC On-going research support: 1 U19 AI078526-01 (Barouch, Dan H.) 8/15/2008-7/31/2013 NIH/NIAID Integrated Preclinical/Clinical AIDS Vaccine Development (IPCAVD) Program Novel Heterologous Adenovirus Prime-Boost HIV-1 Vaccine Roles: PI (Overall Program) PI (Project 1: Preclinical Evaluation of Novel Ad Prime-Boost HIV-1 Vaccine) Co-Investigator (Project 2: Clinical Evaluation of Novel Ad Prime-Boost HIV-1 Vaccine) PI (Core A: Administrative Core) The major goals of this program project cooperative agreement are to develop a novel heterologous rAd prime-boost HIV-1 vaccine and to evaluate this vaccine in rhesus monkeys and phase 1 clinical trials. MV-00-9-900-01431-0-00 (Barouch, Dan H.) 6/1/2008-5/31/2010 Elizabeth Glaser Pediatric AIDS Foundation Immunogenicity of Novel Pediatric HIV-1 Vaccine Candidates in Infant Rhesus Monkeys Role: PI The major goals of this grant are to assess the immunogenicity of novel pediatric HIV-1 vaccine candidates. 5 R01 AI066924-03 (Barouch, Dan H.) 12/15/2005-11/30/2010 NIH/NIAID Novel Adenovirus Vaccine Vectors for HIV/SIV Role: PI see email dtd 08/19/2009 The major goals of this grant are to construct novel chimeric and group D rAd vectors and to evaluate them in preclinical studies. 5 U19 AI066305-04 (Barouch, Dan H.) 7/14/2005-3/31/2010 NIH/NIAID Integrated Preclinical/Clinical AIDS Vaccine Development (IPCAVD) Program Novel Adenovirus Vector-Based Vaccines for HIV-1 Roles: PI (Overall Program) PI (Project 1: Preclinical Evaluation of Novel Ad Vectors) Co-Investigator (Project 2: Clinical Evaluation of Novel Ad Vectors) PI (Core A: Administrative Core) The major goals of this program project cooperative agreement are to evaluate novel serotype rAd vectorbased vaccines for HIV-1 in preclinical studies and to advance the most promising vectors into phase 1 clinical trials. 5 R01 AI058727-05 (Barouch, Dan H.) 2/1/2004-1/31/2009 NIH/NIAID Augmentation of DNA Vaccine-Elicited Immunity to HIV/SIV Role: PI The major goals of this grant are to assess the utility of adjuvants for DNA vaccines in preclinical studies. W81XWH-07-2-0067 (Marovich, Mary A.) 9/1/2008-8/31/2010 Henry M. Jackson Foundation Heterologous Adenovirus/Poxvirus Vaccine Strategy in Rhesus Monkeys Role: PI (Subcontract) The major goals of this subcontract are to evaluate novel heterologous adenovirus/poxvirus vaccine regimens in rhesus monkeys. 1 U19 AI076982-01 (Moore, John P.) 6/23/2008-5/31/2010 NIH/NIAID A Practical Microbicide Based on HIV-1 Entry Inhibitors Roles: PI (Subcontract) The major goals of this subcontract are to investigate the protective efficacy of vaccine-microbicide combinations in rhesus monkeys. #38643 (Haynes, Barton F.) 8/1/2006-7/31/2011 Bill & Melinda Gates Foundation Collaboration for AIDS Vaccine Discovery (CAVD) Nature and Origin of Broadly Reactive Neutralizing Antibodies Role: Co-Investigator (Objective 3: Formulation of Novel Prime-Boost Regimens) The major goals of this consortium are to optimize humoral immune responses elicited by novel HIV-1 vaccine candidates as part of the Global HIV/AIDS Vaccine Enterprise. #38614 (Letvin, Norman L.) 7/1/2006-6/30/2011 Bill & Melinda Gates Foundation Collaboration for AIDS Vaccine Discovery (CAVD) Novel Adenovirus and Mycobacteria Vector-Based Vaccines for HIV-1 Role: PI (Objective 1: Novel rAd Vectors that Evade Pre-Existing Anti-Ad5 Immunity) The major goals of this consortium are to optimize cellular immune responses elicited by novel HIV-1 vaccine candidates as part of the Global HIV/AIDS Vaccine Enterprise. PENDING None Office of RegulatolY Affairs IACUC Protocol Administration Troy M. Hallman, MS, VMD, Diplomate ACLAM ACLAM Hailman, MS, "rd Director of Animal Welfare, Office of Regulatoiy of of Regulatory Affairs 3624 Market Street, Science Center.Suite 301S + Philadelphia, PA 19104 + Phone: 215-573-2540 + Fax: 215-573-9438 215-573-2540. Fax: 215-573-9438 Street, Science Centert Suite 301S. Philadelphia, PA 19104. INSTITUTIONAL ANIMAL CARE AND USE COMMITTEE (IACUC) ANIMAL CARE AND USE COMMITTEE (IACUC) (MUltiple Project Assurance # (Multiple Project Assurance ft A3079-01) FRED FRANKEL 4112 - MJ-Microbiology MI-Microbiology Room 203C 3610 Hamilton Walk Johnson Pavilion PHILADELPHIA, PA 19104-6076 19104-6076 PRINCIPAL INVESTIGATOR PROTOCOL TITLE GRANT TITLE SPONSORING AGENCY PROTOCOL ft PROTOCOL # Dear FRANKEL: below, Felsburg, Chair The documents noted below, for the above-referenced protocol, were reviewed by Dr. Peter Felsburg, Chair of the IACUC above-referenced protocol, were reviewed by Dr. (or his authorized designee) and approved on 14-Aug-2009. 14-Aug-2009. Amendment to change the funding source to N.I.H. (ORS #: 10016769) titled "Novel Heterologous Listeria-Adenovirus N.l.H. 10016769) Mucosal Vaccine F" and also to add Sufen Li to your IACUC protocol. If you have any questions about the information in this letter, please contact the TACUC administrative staff. Contact information in this letter, please contact the IACUC administrative staff. Contact information is available at our website: http://www.upelill.eduJregulatoryaffairs/Contact.html. website: http://www.upenn.edulregulatoiyaffairs/Contact.html. c'' 1-a Thank you for your cooperation with the Committee. Sincerely, ''D A�Q .ti 14-Aug-2009 : FRED FRANKEL FRED : Novel Heterologous Listeria-Adenovirus Mucosal Vaccine F Vaccine F Novel :Novel Heterologous Listeria-Adenovirus Mucosal Vaccine F Vaccine F Novel : NATIONAL INSTITUTES OF HEALTH :705806 6a' ��o w'' d '\ 'If (J ~ " . ___ 1/ Troy H Han, MS, V Director of Animal elfare, IACUC Animal) Revised 7-2007 (1-08) Animal Use Protocol Amendment Form University of Pennsylvania Administrative Modifications 4 J 1]1. i 1\ U 2 2009 2OU This amendment form should This amendmentform should only be used for the specific options locatc4bc(qw. Any usedfor locatMii!?lf(flw. other proposed changes should be written the amendment forIfflL�'iSee/)i(fIliiis other proposed changes should be written on the amend,nentfoSt'..&coj1dj http://w,,,w. upenn.cdu!ree:ulatoryatIairs/animalliacuc-amend-form040 I1O5.doc) http://www.upenn..edu/regulatoryaffairs/animal/iacuc-amend-formO4O OS.doc ) entries. Use this form to request minor amendment to your currently approved Type all entries. Use this form to request aaminor amendment to your currently approved animal use Complete items #1-5 on the form and any applicable items Submit the completed protocol. Complete items #1-5 on the form and any applicable items # 6-9. Submit the completed Affairs, 3624 amendment with the principal investigator's signature to the Office of Regulatory Affairs, 3624 electronic copy to Market Street, Suite 301 S (6006) or fax: 215-573-9438. You must also submit an electronic copy to 3OlS(6006) or fax: 215-573-9438. You iacuc(a)pobox.upenn,edll. iacuc(�pobox.upenn.edu. 1. Principal Investigator: Name: Fred R. Frankel Name: Fred R. Frankel [email] frankelfupenn.edu Signature: �.o ~~~ate: 8/13/09 Phone: _ _ __ Email: _ _ __ Co-Investigator: Name: 2. Co-Investigator: Name: 3. Protocol: Number: 705806 Number: 4. Title: Listeria Vector Development (grant title: Title: Listeria Vector Development (grant title: Engineered Listeria as an AIDS vaccine; P1, Judy Lieberman) Listeria an AIDS vaccine; PI. Judy NIH (through CBR institute for Biomedical Research, Funding Source: NIH (through CBRinstitute for Biomedical Research, Inc.) 5. Type of Amendment: Check all changes that apply and complete the corresponding sections below. that apply and corresponding sections below. opt Phone: 215-898-8730 Email: Phone: 215-898-8730 Email: Z fl C1' 2<. Personnel - addition and/or removal other than principal investigator Personnel addition than Funding agency Protocol or grant title Protocol Location of procedures and/or satellite housing 6. Personnel: For new personnel, complete 6A and 6B below. New individuals must complete Personnel: For new personnel, complete 68 below. New individuals must complete IACUC on-line training, ULAR species-specific lACtiC on-line training, ULAR species-specific training and be current with EHRS training prior to receiving website for prior to receiving full approval. Please see the Trolining section of the IACUC website for approval. Please Training section of the more (Animal more information. Please also complete and attach Form E (Animal Users Risk Assessment also complete and attach Risk Assessment Questionnaire). Personnel Chart: List new personnel that will be working with animals or animal A. Personnel Chart: List allall new personnel that willbe working with animals or animal oy-pro ducts. b by-products. Position/Role Penn ID # lD IACUC on-line training ULAR Hands on Name within the last three years Training Yes or No Yes Yes or No Research Sufen Li 59231973 Sufen Li l8JYES U NO 161YES U NO Z YES DNO Z YES DNO , _____________ Specialist ________________ __________ ((1 Ai For IACUC Use onlya-_ Approved: ~ '~ tV'''''~ Date: This amendment is now incorp ted into this p~lwhich expires on ______________ incorpO(: ted into this pfetecl which expires ForMCucUseOnlY)jiL r.I I " )il ~I ~j Date:_______ vii .-2 DYES ENO I BYES DNO YES ONo EYES DNO DYES ONo I BYES DNO YES DYES DNO listed above. Be sure B. Qualifications: List the qualifications B. Qualifications: List the qualifications of each individual listed above. Be sure to of include: degree(s), years of experience with the species, skills and specific include: procedures described in the protocol that they will participate in (i.e. surgery, blood in draw, injections, euthanasia, tissue harvest, imaging, etc.) draw, Sufen Li has a BS degree from School of Medical Instrument in Shanghai and an in Shanghai and Sufen Li MSe from the University of Tsukuba in Japan, where she performed mouse iniections of mouse injections MSc from her and tissue isolations. Here we have been demonstrating for her our techniques for Here we have been demonstrating and intragastric intravenous injections of mice, as well as isolation of major tissues jgastric andand intravenous injections of mice, as well as isolationof maior tissues and organs. She has completed mouse training prerequistite (12/11/08), quarantine She has completed mouse training prerequistite (l2Illl08), quarantine (l11l9/081. IACUC (! 1130/08), and hands-on training for rodents (11/19/08), regulations and the IACUC (11/30/08), and hands-on mouse training (2/04/09). b-0 7, Funding Agency: If you are changing/adding the funding source, please provide the old and 7. Funding Agency: If you are changing/adding the funding source, please provide the old and Office of Research Services. If you have not provided by the new Tracking Numbers provided by the Office of Research Services. If you have not previously submitted the grant application covering this work, please provide a copy (minus provide a appendices). (Contact your BA or Call ORS at 215-898-7293 to find out your number). out your number). A, Old ORS Tracking Number: 04644000 A. Old ORS Tracking Number: 04644000 B, New ORS Tracking Number: 10016769 B. New ORS Tracking Number: 10016769 ... �N' 8, Protocol Title: Novel heterologous Listeria-adenovirus mucosal vaccine for HlY-I HIV-I 8. Protocol Title: Novel heterologous Listeria-adenovirus Grant Title: Novel heterologous Listeria-adenovirus mucosal vaccine for HIV-1 Grant Title: Novel heterologous Listeria-adenovirus mucosal vaccine for HIY-l 0.. s.' a.0 9, 9. Location of Procedures and/or Satellite Housing: IfIf yourlab has moved to another Procedures and/or Satellite Housing: your lab has moved to another if will be a new location not building/room or if you will be performing approved procedures in a new location not procedures mentioned in the original submission please complete the following chart. If the procedures please complete the following chart. If please Compliance Office (215-746-6271) to have involve surgery and/or housing please contact the Compliance Office (21 5-746-6271) to have use. the space inspected prior to use. L2. ova Procedure(s) Building # Room ft ...... L.-J.C;-.::::~111j U(l r U .1uuo un;OD r" uo,, / ~IJ\.IO U (I; "o , '_' k::)'( : 44 i7:44 ------------_ --p<0-:-t:+4 i l _ _ _ _ - - - - - - - - - - - - - - - - - _ Yl.KAL "'.0\111 VLK&L PAflj \ l~~- .~ HRRLJPRD HARVARD ns, ,a O~I I~~ ~azl MEDICflL M EDICAL . 1/LWISIU.N Ut lJ J. \, l :;lUN In' -- 51? 432 3159 617 3169 I ~00 2 P , 01 / 02 P.0122 ,l,UG - 1ThUS i i 20QS PROTOCOL NUMBER: PROTOCOL NUMBER: 04S2 t. 0+52 (p ' ......... -., ....... Subic;d P~o)edion' . Harvard M9dical Are" (HMA) Standing Committee on Animals -- "Established In 1907" Medical Aree (HMA) Standing Comniitteu n Animals "E:st~blish"d In iso?" Harvard Medical School - Office for Revearch Subject Protection Harvard Medical School - Office for R.. ".arch Subject Protection Fax: 617-432219 Tel:: 617-432-3192 107 Ave , Louis PasteUr, Annex Pasteur, Bos10n. MA 02115 0:2115 Tel 17-432-31Y2 Fax: 617-432-3169 Boslon, 107 Ave. http://wwW.hms,harvard .eduIQrsp/ hms. harvard.edulprspi .; [email] [email] . .... , . ., - ANIMALEXPERI1V1ENi.~TIQ"i PRqTOCtil .. " . .. . .. . '. ' . ANWALEXPERIWIENIATIQN.PROTOcOL - H Principal Investigator Investigator Harvard Harvard Appointment Title Dan H. Barouch MD, PhD Dan H. Barouch. MD, PhD - As.ooiate Professor of Medtcine As;ociate Professor of Medicine , '10'.) do no' hlille Harvard fa.culty aPFlOl"lment, pravlce InQ name 0 ~ _pol1sol wit" I-larvard facoity oppo,nlflienl .and mdude ~(lt;:I' tl...